Inhibition of phosphatase activity as a novel treatment for chronic toxoplasmosis

DESCRIPTION (provided by applicant): This application addresses latent chronic infection caused by the protozoan parasite Toxoplasma gondii. In the host, Toxoplasma converts from a proliferative stage (tachyzoite) that causes acute infection to a latent cyst (bradyzoite) stage tht establishes a lifelong chronic infection. Chronic toxoplasmosis is of great clinical importance because the latent infection can reactivate into life-threatening acute toxoplasmosis, most notably in AIDS and heart transplant patients. This application addresses the significant need to develop therapies that can prevent latent cysts from reactivating infection. Our previous findings established a role for eIF2α (eukaryotic initiation factor-2) phosphorylation in microbial latency, prompting us to test if inhibitors of eIF2α dephosphorylation could interfere with reactivation of latent Toxoplasma infection in vitro. We found that one such drug, guanabenz (GA), is a potent anti-parasitic agent that also inhibits the reactivation of bradyzoite cysts in vitro. Importantly,GA is a well-tolerated FDA-approved drug that crosses the blood-brain barrier, properties that make it an outstanding candidate for rapid advancement as an innovative new treatment for chronic toxoplasmosis. In the R21 phase of this application, we will test the utility of GA in a well-characterized mouse model of chronic infection, and conduct a screen for GA-resistant parasites in order to assess the likelihood and mechanism of drug resistance. These mutants will facilitate studies to define how this drug inhibits parasite proliferation and the reactivatio of infection. Milestones for advancement to the R33 phase include either a demonstration of GA activity against chronic Toxoplasma in vivo or the generation of GA-resistant mutants. If one or both of these milestones are achieved, the R33 phase of this study will elucidate the molecular mechanism underlying the ability of GA to control parasite replication and latent infection using complementary biochemical and genetic approaches.

Public health relevance
PUBLIC HEALTH RELEVANCE: Toxoplasma gondii is a parasite that causes life-threatening disease in immunocompromised patients due to its ability to remain in the host for life as a latent cyst form. We have identified an already FDA-approved drug that blocks reactivation of Toxoplasma infection in vitro. Our proposal aims to test this drug in the mouse model of Toxoplasma infection and understand the molecular mechanisms by which this drug can prevent reactivation of this latent infection, which has the promise of rapidly advancing a new and innovative prophylactic treatment for toxoplasmosis and possibly other latent parasitic infections. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This R21/R33 proposal, in response to RFA-AI-12-020, addresses latent chronic infection caused by the protozoan parasite Toxoplasma gondii. In the host, Toxoplasma converts from a proliferative stage (tachyzoite) that causes acute infection to a latent cyst (bradyzoite) stage that establishes a chronic infection that remains with the patient throughout his/her life. Chronic toxoplasmosis is of great clinical importance because the latent infection can reactivate into life-threatening acute toxoplasmosis during immune suppression (3). Consequently, Toxoplasma is the leading protozoal opportunistic infection in immunocompromised individuals, especially AIDS and heart transplant patients (4). This proposal addresses the significant need to develop therapies that can treat the chronic stage of infection and prevent latent cysts from converting into acute toxoplasmosis. The molecular mechanisms orchestrating Toxoplasma conversion from bradyzoite cysts to the life threatening tachyzoite stage are poorly understood, but we found that phosphorylation of the Toxoplasma alpha subunit of eukaryotic initiation factor-2 (TgIF2α) coincides with bradyzoite development (1). Moreover, TgIF2α is maintained in its phosphorylated state in mature bradyzoite cysts (2). Recent studies in the related malaria parasite, as well as kinetoplastids, also strongly support the idea that eIF2α phosphorylation (eIF2α~P) is critical for latent parasite stages (5-7). Phosphorylation of eIF2α in eukaryotes dramatically reduces global translation in favor of mRNAs encoding transcription factors that regulate adaptive response genes (8, 9). We proposed that phosphorylation of parasite TgIF2α induces translational control that reprograms the genome to express factors promoting and maintaining latency (3, 10). Further support for the role of TgIF2α phosphorylation in bradyzoite cyst conversion comes from our new studies using the drug salubrinal (Sal), a selective inhibitor of eIF2α dephosphorylation. In mammals, Sal binds GADD34 (PPP1R15A), a regulatory subunit of protein phosphatase 1 (PP1) that targets PP1 to eIF2α~P for dephosphorylation (11). Mammalian cells treated with Sal have reduced dephosphorylation of eIF2α, leading to an accumulation of eIF2α~P, which elicits translational control. We reported that Sal can act directly on Toxoplasma and Plasmodium to inhibit dephosphorylation of parasite eIF2α (2, 5). It has recently been discovered that the drug guanabenz (GA) also inhibits eIF2α dephosphorylation in stressed human cells through interaction with GADD34, which enhances survival by augmenting expression of adaptive genes (12). Importantly, we show here that latent bradyzoites fail to reactivate into tachyzoites in the presence of Sal or GA, in a dose-dependent fashion. Additionally, Sal and GA significantly slow the replication of tachyzoites. Together, these data demonstrate that TgIF2α dephosphorylation inhibitors are effective against acute and chronic stages of Toxoplasma. GA offers important advantages over Sal that makes it the focus of this proposed study. GA is a safe, FDA-approved drug that is already in clinical use for hypertension. Second, GA crosses the blood-brain barrier, which is necessary to target latent bradyzoites (or reactivated tachyzoites) in the brain. We hypothesize that GA offers a new treatment strategy for minimizing the establishment of chronic infection and blocking reactivated toxoplasmosis by enhancing TgIF2α phosphorylation and eliciting the translational control underlying cyst formation. The R21 phase of this study has two aims: Aim 1) Determine the activities of GA against the establishment and reactivation of latent toxoplasmosis in vivo using a well-characterized mouse model. Aim 2) Develop Toxoplasma mutants that are resistant to GA. GA-resistant mutants will allow us to address the likelihood and mechanism of drug resistance and facilitate studies to define how this drug inhibits parasite proliferation and the reactivation of latent infection in vitro. Milestones for advancement to the R33 phase include either a demonstration of GA activity against chronic Toxoplasma in vivo or the generation of GA-resistant mutants to identify additional targets for future drug design to treat latent forms. The R33 phase of this study will center on elucidating the mechanism of action underlying the ability of GA to control parasite replication and latent infection by pursuing complementary biochemical and genetic approaches. Aim 1) Identify genes associated with GA-resistant mutants developed during the R21 phase. Aim 2) Elucidate the regulatory subunits of the TgIF2α dephosphorylation complex controlling Toxoplasma latency. Aim 3) Identify parasite proteins that bind to GA. The putative GA targets identified in each aim will also be tested to address their role in parasite latency. This study will determine if the FDA-approved drug GA can rapidly advance as a novel prophylactic against reactivated toxoplasmosis in susceptible infected patients. Additionally, our studies will greatly advance our understanding of Toxoplasma latency mechanisms with an eye towards new insights into the application and underlying mechanisms by which GA prevents reactivation of latent infection and parasite proliferation.